PHENIX: new methods for automation in macromolecular crystallography

Program Director/Principal Investigator (Last, First, Middle): Adams, Paul D. Use only if additional space is needed to list additional